Acquisition of Bruker 900 MHz NEO console and probes

PROJECT SUMMARY/ABSTRACT
This S10 grant application requests funds to purchase a modern 900 MHz NMR spectrometer console and
probes that would leverage the unique opportunity to rescue a Bruker US2 900 MHz (21 Tesla)
superconducting magnet that would otherwise be lost to the US scientific community. The University of Illinois
at Chicago (UIC) operated this instrument at its Center for Structural Biology since its purchase with NIH funds
and installation in 2004 (Gettins, P41GM068944). UIC has recently determined that it is no longer able to keep
this instrument running and approached the National Magnetic Resonance Facility at Madison (NMRFAM) at
the University of Wisconsin-Madison (UW-Madison) to request that NMRFAM move and update this instrument
for the benefit of the overall scientific user community. NMRFAM has all the infrastructure in place, including
helium recycling capability, to maximize long-term effective operation of this instrument. NMRFAM also has
expert staff to maintain this instrument and ensure it operates in the most efficient manner to produce high-
quality research results for our user community. NMRFAM has well-established procedures for user access,
training and data management. Bruker has already de-energized the magnet and the full costs of the magnet
move have already been committed by UW-Madison. The request of this proposal is solely for the NEO
console and probes, one for solution NMR and one for solid-state NMR, that would most substantially update
the performance of this system and thereby have the most immediate and lasting impact for a large group of
NIH-funded investigators in need of high field NMR resources. With demand for 900 MHz NMR time by the
NMRFAM user community at historically high levels exceeding our current capacity, this instrument will meet
the demand for access to 900 MHz solution and solid-state NMR capabilities in a well-established shared
facility. The proposed acquisition would also bring new NEO console technology and ultrafast (>100kHz) MAS
capabilities to the NMRFAM user community, addressing requests for these cutting-edge technologies.
Therefore, this proposal presents a special opportunity to most effectively steward precious scientific resources
for the nation and to make a high-performance NMR spectrometer available to the user community for a
fraction of the price of a new instrument.

Public health relevance
PROJECT NARRATIVE The proposal is to equip a powerful superconducting magnet, which is being moved from the University of Illinois at Chicago to the University of Wisconsin-Madison, with a modern electronics console and detectors (probes) for performing nuclear magnetic resonance (NMR) spectroscopy with especially high data quality. The instrument will be housed in the National Magnetic Resonance Facility at Madison, a national user facility with a long history of supporting the scientific user community in the United States, in order to ensure that a large range of biomedically significant research projects can continue with minimal interruption. These ongoing user projects are actively contributing to the improved understanding of bacterial drug resistance, neurodegeneration, fungal infections, blood coagulation, and cancer among other highly significant challenges in modern human medicine that are central to the mission of the National Institutes of Health.